Resource Core

PROJECT SUMMARY: RESOURCE CORE COMPONENT
The Squirrel Monkey Breeding and Research Resource (SMBRR) provides squirrel monkeys, tissues,
biological fluids, information on the care and use of squirrel monkeys, and research services to the
biomedical research community. The breeding colonies of the SMBRR include two species/subspecies of
squirrel monkeys including Bolivian squirrel monkeys (Saimiri boliviensis boliviensis) and Guyanese or
common squirrel monkeys (Saimiri sciureus sciureus). Due to bans on the export of Bolivian squirrel
monkeys, the SMBRR is the only source in the world of this important squirrel monkey species and the only
source of laboratory-born and pedigreed squirrel monkeys of any species. While NIH grantees, the NIH
intramural research program, and federal agencies, including the FDA and NSF, will continue to receive
priority access to these resources, the SMBRR also provides access to other sponsors of biomedical research
(private foundations, pharmaceutical companies, and contract research organizations). The overall goals of
the Resource Component of the SMBRR are to provide a national research resource of squirrel monkeys and
squirrel monkey derived biological materials; provide education and training to scientists, veterinarians,
colonymanagers, and animal caregivers who work with squirrel monkeys; and, support investigators who
need facilities and expertise to conduct studies using squirrel monkeys. New areas of research continue to
emerge that need squirrel monkeys. As these new areas of research develop, the SMBRR plays an essential
role by providing the animals, biological resources, and the expertise needed. Over the next five years, the
SMBRR will continue to provide squirrel monkeys and related resources to the scientific community and
continue to increase the value of the squirrel monkey as a model for biomedical research. The scarcity of
squirrel monkeys, difficulties associated with captive breeding, challenges associated with their care and use
in research, all contribute to the need to continue this NIH supported national research resource.